Integrating the Visualization and Use of Stigma Data to Maximize the Impact of the Ending the HIV Epidemic Initiative

The 2021-2025 HIV National Strategic Plan (HIV Plan) recognizes stigma as a barrier to the success of the
Ending the HIV Epidemic (EHE) initiative given consistent data highlighting the relationship between stigma
and suboptimal HIV testing, prevention, and treatment outcomes. The prioritization of stigma by government
agencies has yet to translate to scaled stigma mitigation strategies as a means of improving mental health,
quality of life, and optimizing the HIV response. In response, our goal is to address the disconnect between
practice and priorities in HIV epidemic control by systematically collecting stigma data in partnership with
seven health departments and community partners in priority EHE areas, systematically visualizing key stigma
indicators and the potential impact of stigma mitigation on EHE pillars and local HIV incidence, and using
implementation research to optimize the usability of these tools and inform stigma mitigation interventions.
These goals will be achieved via the following specific aims:
Specific Aim 1 – Use historical and future iterations of data from AMIS, TWIST, PLHIV Stigma Index 2.0,
NHBS, combined with systematic reviews to create stigma dashboards integrated into AIDSVu.
Specific Aim 2 Using stigma data to model and visualize the effects of stigma and stigma mitigation
interventions on proximal EHE indicators including incidence, knowledge of status, diagnoses, linkage to HIV
care, viral suppression, and PrEP coverage.
Specific Aim 3 – Use qualitative methods with health departments and CBO partners to inform the
optimization of the Stigma Dashboard including usability, presentation, and information included to inform
stigma-related policies and the development of local stigma mitigation strategies.
These aims are highly responsive to “Respond: Epidemiology to End the HIV Epidemic” in using data to support
effective and tailored approaches to respond to local epidemics and include balanced collaborations between
epidemiologists, data scientists, statisticians, and local health departments and community partners. The key
outputs of the proposed research will include refined, user-centered stigma dashboards integrated into AIDSVu
that allow for data visualization and tools to plan and assess downstream impacts of intervention, as well as
guidelines to support implementation of use of stigma dashboards and support connection to evidence for stigma
mitigation intervention planning to achieve HIV epidemic control goals in additional health departments. While
an ambitious research agenda, the diverse experience and competencies of this investigative team focused on
stigma and existing partnerships makes us well placed to be successful in contributing to the Ending HIV
Epidemic plan through improved measurement, use of, and response to HIV-related and intersectional stigmas.

Public health relevance
Stigma remains a fundamental barrier to the HIV response in the US and around the world reflected as a priority by both government agencies and community partners. However, stigma data remains underutilized and stigma programs achieve limited scale if implemented at all. We posit that the proposed research builds on solid scientific premise and holds tremendous promise to advance the response to stigma and improve the quality of life of people affected by stigma in the US and ultimately facilitate progress in meeting HIV testing, prevention, and treatment goals as described in the Ending the HIV Epidemic Initiative.